Development of Artificial Intelligence-Based Approaches for Computer-Aided Management of Colorectal Polyps

Background and Objectives: Colorectal cancer (CRC) is the second leading cause of cancer death in the
United States, with nearly 150,000 new cases and 50,000 deaths annually. Colonoscopy with polypectomy
remains the gold standard for CRC screening and surveillance since removal of neoplastic polyps during
colonoscopy modifies disease outcomes and informs subsequent management. Standard practice
continues to favor removal of all visualized polyps for histopathological assessment, despite estimates that
nearly half of the polyps are non-neoplastic. Studies have shown that the capability to reliably predict polyp
pathology endoscopically in real time could result in substantial improvement in the cost-effectiveness of
colonoscopy for CRC. The number of colonoscopies performed is increasing, and in the VA more than
doubled in a five-year span. This demand does not include subsequent procedures required in ~30% of
screened patients. Thus, colonoscopy can benefit greatly from efficiency improvements at every level. In
light of this, the past decade has seen an explosion in advances in endoscopic technologies toward
diagnosing and treating colorectal neoplasia more precisely. Recent advances in artificial intelligence (AI),
specifically in the field of deep learning, and their application to endoscopic imaging, have shown promise
for automating endoscopic polyp pathology predictions, overcoming operator-based polyp pathology
assessment factors such as interobserver variability, skill, and experience. Such capability would finally
open the door to widespread adoption of cost-saving resect-and-discard and leave-behind paradigms for
diminutive polyps, as proposed by the American Society for Gastrointestinal Endoscopy Preservation and
Incorporation of Valuable Endoscopic Innovations guidelines. More importantly, the incorporation of AI-
based quantitative image interpretation into clinical practice, including in the VA, has the potential to
increase early cancer detection thus reducing patient morbidity and mortality. To this end, the main goal
of the proposed study is to leverage AI, specifically deep learning models, to develop an accurate and
robust computer aided diagnosis (CADx) platform to enable the purely endoscopic, optical assessment of
mucosal pathologies, specifically colorectal polyps. In parallel, the use of AI models to assess colonic
mucosal and luminal features known to inform colonoscopy quality will be investigated.
Methods: The study will be guided by three aims. In Aim 1 robust classification models for predicting polyp
pathology will be developed. Labeled images and clinical data, from existing datasets and clinical records,
will be used to design and validate deep learning models. The design will consist of two steps: outlining
regions in an image containing a polyp, and subsequent analysis of the polyp region to provide a pathology
prediction. Borrowing from aspects of augmented reality, the pathology prediction along with the estimated
polyp boundary, will be presented to endoscopists in an intuitive and clinically friendly manner as a pseudo-
color overlay, enhancing the transparency and interpretability of the models output predictions. This
immediate visual feedback can thus inform clinical decisions during colonoscopy. Aim 2 will focus on using
clinical risk factors associated with colorectal neoplasia in combination with endoscopic imaging data to
enhance predictions of polyp pathology. The goal is to investigate incorporation of recognized CRC clinical
risk factors and biomarkers, obtained from patients’ electronic health records, in our polyp pathology
prediction deep learning models. Finally, in Aim 3 the deep learning-based detection, segmentation, and
classification frameworks developed in Aim 1 will be adapted for scoring bowel preparation, recognizing
cecal landmarks and rectal retroflexion, identifying colonic diverticula, and delineating endoscopic tattoo
markings. These features are associated with performing of high-quality colonoscopy, for which automated
identification could improve and facilitate documentation of endoscopic findings and report generation.

Public health relevance
The potential benefits of this study are improvements in the diagnosis of precancerous polyps during colonoscopy, and enhancements in the quantification of colonoscopy quality measures. The study will focus on validating the use artificial intelligence to teach computers how to use endoscopic images to automatically classify polyps and other landmarks in the colon seen through the endoscope. One feature of our approach is that we use augmented reality to present the results from artificial intelligence predictions to endoscopists. This gives endoscopists immediate intuitive visual feedback about the polyp’s classification. Additional potential benefits of this research relating to healthcare include the following: 1. Real-time diagnosis of polyps would reduce the number of biopsies of benign tissue, significantly reducing procedure risks, costs and healthcare burden. 2. More thorough surveillance examinations could be performed to minimize missed precancerous polyps, thus decreasing cancer risk.